ADMINISTRATIVE CORE

CORE 1 will provide the administrative coordination, oversight, and logistical support for the entire Conte Center It will hire a part-time administrative staff who is currently laboratory administrator for the PI and whose duties already entail grant management, coordination with the Caltech Brain Imaging Center, and supervision of other staff. This Core includes support for visits of all the PIs to NIH for annual meetings, visits for the Advisory Board to Caltech annually, travel for off-site collaborators to attend NIH site visits, and maintenance of a website dedicated to the Conte Center. There are three Aims: to coordinate and communicate internally among all the investigators of the Conte Center to facilitate the science proposed; to coordinate the best teaching and training of graduate-students, post-docs, and undergraduates; and to coordinate and communicate between the investigators of the Conte Center and the outside research community, NIH, and the larger public.